Cancer Data Science (CDS)

The mission of the Cancer Data Science Shared Resource (CSD-SR) is to enhance the scientific excellence of
research at Rogel Cancer Center (Rogel) by providing biostatistical, bioinformatics and clinical informatics
support across the spectrum of basic, translational, clinical and population sciences research. CDS-SR
consists of highly trained quantitative scientists (faculty and staff analysts) who assist Rogel investigators to
execute data analyses and conceptualize and develop research projects and clinical trials. CDS-SR personnel
collaborate with Rogel members for dissemination of analytical findings in the form of inferences and
hypotheses for validation and interpretations for publication.